Protein kinase C signaling in prostate cancer health disparities

ABSTRACT
Prostate cancer (PCa), the second leading cause of cancer-related deaths among men in the US,
disproportionally affects men of African American (AA) descent, who exhibit greater incidence, faster disease
progression and higher rate of mortality than men of European descent (EA). AA men are more likely to present
high-grade disease and distant metastasis at the time of diagnosis. The drivers of this disparity are multifactorial,
and include socioeconomic, lifestyle and biological factors. Current evidence suggests genetic alterations - such
as changes in oncogenic and tumor suppressive genes associated with PCa progression - and the presence of
a more inflammatory tumor microenvironment (TME) in prostate tumors from men of African descent as major
underlying causes of this racial disparity. However, there is still a limited understanding of the molecular/signaling
foundations behind the racial differences in PCa. Here, we identified the diacylglycerol-regulated kinase PKCa
as a potential contributor towards racial disparities in PCa. We found PKCa to be aberrantly overexpressed in
aggressive PCa cell lines as well as in human PCa. Interestingly, silencing PKCa expression from PCa cells
impairs their invasive capacity as well as their ability to form tumors in mice. An in-depth RNA-Seq transcriptome
analysis integrated with existing database inquires established PKCa as a crucial determinant for the expression
of cytokines known to be dysregulated in prostate tumors from AA men. Most remarkably, expression analysis
in patient-derived xenografts (PDXs) revealed higher PKCa levels in AA relative to EA prostate tumors, which
associates with the expression of epithelial-to-mesenchymal transition (EMT) markers. This led us to hypothesize
that excessive activation of PKCa signaling may contribute to racial disparities in PCa. In Aim 1 we will take
advantage of a large collection of primary and metastatic human PCa tumors both from AA and EA men to test
the hypothesis that there is disproportionate PKCa expression and/or activation in AA PCa. We will establish
potential correlations with Gleason score, disease recurrence and metastatic disease in the available cohorts of
AA and EA prostate tumors. In Aim 2 we will use both genetically engineered and syngeneic models towards the
goal of establishing the in vivo functional relevance of PKCa in prostate tumorigenesis and metastasis. Racial-
related cell/tumor growth differences will be established using EA vs. AA PDXs and organoids derived from these
racially diverse set of PDXs. In Aim 3 we will pursue a thorough profiling of immune cell populations and cytokine
expression in mouse prostate tumors upon inducible silencing of PKCa. Transcriptome signatures will be
established both in mouse models as well as in EA vs. AA PDXs to identify racial differences in PKCa-driven
gene expression. This will provide a comprehensive perspective on how tumor cell PKCa contributes to the
generation of a pro-inflammatory tumorigenic state and an immunosuppressive landscape, and unearth
associated differences based on racial distinction. Our studies should provide exceptionally valuable information
on the oncogenic and metastatic pathways leading to racial disparities in PCa.

Public health relevance
NARRATIVE The main goal in this application is to establish whether the PKCa signaling pathway contributes to outcome disparities observed in PCa in AA men. Our studies identified the kinase PKCa as an essential player in prostate cancer cell growth, tumorigenesis and invasion. We speculate that cancer cell PKCa plays a major role in the regulation of cytokine production and tumor immune cell populations, which contributes to PCa racial disparities. 1